SAFETY AND EFFICACY OF VARYING DOSES OF ERGOSET IN OBESITY

This is a corporate-sponsored Phase II/III trial of the efficacy and safety of two dosages of Ergoset (bromocriptine mesylate) compared to placebo in inducing loss of weight and body fat, and improving metabolic parameters, among obese adults. Screening began August 26, 1997. As of now, 56 people have been screened, 34 were randomized, and of those 13 have dropped or been terminated. The first patient to finish should do so in March 1998. The inpatient GCRC is being used for an overnight admission with multiple blood draws the following morning at the beginning and end of the 6 month protocol.